COMBINED ERYTHROPOITIN/HYDROXYUREA THERAPY FOR SICKLE CELL ANEMIA

Increasing doses of recombinant erythropoietin are injected to assess their effect on fetal hemoglobin production, in comparison and in conjunction with hydroxyurea.